The metabolic clock as a regulator of cell fate decision

Project Summary:
Our organs respond dynamically to changes in the body’s demands by adapting both their size and activity
levels. In these processes, mechanisms governing cell fate decisions, which influence the equilibrium between
cell death and cell proliferation, assume crucial roles. Although decades of research have revealed the
involvement of cell cycle regulators, epigenetic modulators, metabolic pathways and ionic homeostasis in this
complex decision process, we still have major gaps in our understanding of the mechanisms that govern cell
fate. These gaps need to be addressed in order to better understand the pathophysiology of many life threatening
conditions stemming from the errors of cell fate decision, such as uncontrolled cell death seen in degenerative
diseases or uncontrolled cell proliferation in neoplasms and autoimmunity. Our recent work showed that B cell
fate is regulated through two spatiotemporally distinct signals, 1- by antigen binding to the B cell receptor (BCR),
and 2- via T cell help or pathogen-driven activation of the toll-like receptors (TLRs). While signal-1 primes the
cell for activation and proliferation, it also initiates a short countdown to death that can be halted by a “signal-2”.
The presence of signal-2 promotes cell survival and proliferation by validating the accuracy of the signal-1, while
its absence causes a gradual increase in intracellular calcium leading to mitochondrial dysfunction and cell death.
We called this process the ‘metabolic clock’. Because mitochondria and calcium homeostasis have been shown
to play roles in determining the fate outcomes of many different cell types; our metabolic clock model provides
an excellent platform to dissect the mechanisms that govern life and death decisions throughout the body. The
overarching goal of our proposal is to unveil the interplay between signals -1 and -2 at the molecular level, with
a view towards identifying how metabolic clocks regulate cell fates. Our first project will define how signal-1
induces calcium increase, the main driver of mitochondrial dysfunction, and how this can be prevented by signal-
2 to promote survival and proliferation. Our second project will delineate whether mitochondrial remodeling,
under the influence of signals -1 and -2, can modulate the metabolic clock by altering the sensitivity of
mitochondria to rising cytoplasmic calcium. Lastly, we will reveal whether the metabolic clock may lead to cell
fates other than death or proliferation, such as the induction of an hypofunctional anergic state. We will use
transgenic mouse models, novel bone marrow chimeras and human samples to perform integrated sets of
biochemical and cellular assays, unraveling how the two signals independently or in combination impact
activation of signaling molecules, mitochondrial remodeling, calcium dynamics, and energy production pathways.
Altogether, this proposal, bridging basic mechanistic research with in vivo models, will provide a novel
perspective of cell fate decision mechanisms, paving the way for new therapeutic approaches to disorders
caused by the errors in this process.

Public health relevance
Project Narrative: Decisions of fate for an activated cell are complex processes that are tightly regulated in the human body to ensure organ functionality while safeguarding against deleterious consequences of uncontrolled cell proliferation or death. One such mechanism, namely the metabolic clock operates as a countdown to self-destruction through metabolic instability, which is initiated when a cell receives an activation signal and can only be defused by receiving secondary signals validating the initial stimulus. Our proposed studies will elucidate the mechanistic underpinnings of the metabolic clock and identify molecular targets that can be used for generating novel therapeutics against disorders stemming from errors in cell fate decision processes, including degenerative diseases, malignancies and autoimmune conditions.